Core B: Human subjects

PROJECT SUMMARY/ABSTRACT – CORE B
The Clinical Research Center is supported by Core B (Human Subjects). Core B (Aim B.1) is
responsible for recruitment of female and male human subjects representing the population of the local
community for participation in (1) the longitudinal study of age-related hearing loss, (2) experiments proposed
in Project 3 and Project 4, (3) donation of DNA for experiments proposed in Project 1, and (4) donation of
human temporal bones for experiments proposed in Project 1 and Project 2. Core B (Aim B.2) manages the
collection, storage, and analysis of demographic, audiologic, and biologic/medical data and tissue (blood and
DNA) from human subjects. These data define the basic audiologic profile of each subject, supplemented by
measures that may be associated with this profile, and are organized into a searchable database, which
provides key information needed to recruit subjects according to the enrollment criteria for each scientific
project. Together with Aim B.1, the goal is to ensure the scientific projects enroll the required numbers of
subjects with various audiologic profiles, obtain the required numbers of DNA samples, and acquire sufficient
numbers of human temporal bones. Core B (Aim B.3) coordinates subject schedules for the human subject
protocol (longitudinal measures and annual evaluations), Otolaryngology clinic visits, and laboratory visits for
blood draws for clinical chemistries and DNA. Because of the strong links among projects, there is substantial
overlap of needs for subject participation. Thus, Core B makes efficient use of subjects' testing time and
coordinates storage of their data to optimize data access and analyses for the scientific projects.

Public health relevance
PROJECT NARRATIVE – CORE B The Project Narrative is included in the Overall Component, as per the Parent Announcement, PAR-19- 137, NIDCD Clinical Research Center Grant (P50 Clinical Trial Optional).